Precision Delivery and Imaging to Enhance Solid Tumor Therapy

PROJECT 1 SUMMARY
Existing antibody-based interventions for cancer rely on passive delivery of the circulating
drug that depends on a large concentration gradient across the semi-permeable wall of
blood vessels to get inside tumors. The forces driving the drug from the bloodstream into
tumors result in sub-optimal delivery and poor access to tumor cells, in part because
endothelial cells (EC) forming the vascular wall constitute a significant, limiting barrier.
We intend to boost precision delivery into primary and metastatic tumors by overcoming
the vascular EC barrier through a highly precise, active transport pathway that we
discovered through proteomic imaging and named the caveolae pumping system. The
approach proposed here to enhance delivery goes well beyond typical so- called 'active
targeting' of antibodies. Our lead humanized antibody against Annexin A1 (hAnnA1), a
tumor- specific antibody concentrated in EC caveolae, not only binds its intended target
but is actually the first antibody to penetrate solid tumors actively, rapidly and specifically.
It does so even at very low dosages and reaches unprecedented intra-tumoral
concentrations well beyond the highest blood levels after injection. It is now time to test
this unprecedented immunotargeting in humans. We propose here to develop a
radiolabeled humanized mAnnA1 to detect and destroy primary and metastatic lesions.
Major aims of this project are to: 1-2) evaluate in vivo delivery and efficacy of novel
caveolae-targeting radioimmunoconjugates in hard-to-treat metastatic tumor models of
breast cancer; 3) test the effectiveness of caveolae pumping in human tumor blood
vessels using PDX and novel human IVM tumor models; and translate hAnnA1 towards
clinical testing. We will 4) determine here the degree to which caveolae can be targeted
to pump radiolabeled antibodies across vascular EC to concentrate them inside solid
tumors as means to improve image-guided drug delivery and enhance
their efficacy. Antibodies will be provided by Core B and radiolabeled with assistance
provided by Core D for preclinical work. Several mammary tumor models will be used to
assess the ability of radiolabeled hAnnA1 to target primary and metastatic tumors via
imaging services provided in Core C. We will study by intravenously injected hAnnA1 with
advanced multimodality in vivo imaging to quantify and optimize precision transvascular
delivery and tumor penetration. As the utility of caveolae targeting in humans requires
AnnA1 expression in tumor EC caveolae, we will use Core C imaging services to compare
vascular expression of AnnA1 in preclinical tumor models and human tumors. To translate
our findings for clinical testing, we will test hAnnA1, humanize further if needed and
partner with NCI's NExT program for cGMP production, quality control and toxicology of
hAnnA1. With Core D, Project 3 will optimize hAnnA1 radiolabeling necessary to conduct
a first-in-human imaging trial as a direct result of successful translation of our findings
from Project 1 into the clinic.

Public health relevance
OVERALL PROJECT NARRATIVE Existing drug therapies for cancer rely on passive delivery into solid tumors and have limited ability to penetrate tumors, which can greatly curtail therapeutic activity. Our strategy is to boost delivery by >100-fold by exploiting an active transport pathway we discovered that concentrates antibodies and drugs precisely inside solid breast tumors and exhibits greatly improved therapeutic efficacy in preclinical models. This program intends to translate our new delivery system into the clinic to generate and test the first precision imaging and therapeutic agent, and if successful, could yield a paradigm shift in how drugs and diagnostic agents are delivered to treat cancer and metastatic disease.